Preconception and prenatal stress effects on cardiovascular disease risk in black women - Diversity Supplement

Project Abstract
This Diversity Supplement aims to contribute to my professional and career development and
ultimately assist in preparing an F31 application to evaluate further how digital storytelling, as a
critical narrative intervention, can help facilitate interpersonal conversations about preeclampsia
and its related risks in Black families. Preeclampsia, a severe hypertensive pregnancy disorder
(HDP), poses a significant health risk and disproportionately affects Black women. While
identifying and treating Black maternal health inequities is a public health priority, limited
attention has been given to how Black women understand and communicate their preeclampsia
experiences and family history, highlighting a gap in knowledge regarding intergenerational
communication and the impact of preeclampsia on Black families. Under the guidance of my
mentorship team and enhanced by the training from this Supplement, I will utilize innovative
visual participatory methods such as zine-making and family tree interviews to explore Black
women's experiences, knowledge, and perspective regarding preeclampsia. The Specific Aims of
this study are to 1) Explore how mothers of Black study participants perceived their experiences
with preeclampsia using zine-making and 2) Examine Black women’s knowledge and
perspectives on preeclampsia. To accomplish the proposed research, I will implement a
comprehensive training and mentorship plan to build on my prior maternal health knowledge,
research experience, and doctoral training. Specifically, my Training Goals will focus on
expanding my knowledge and/or skills in 1) qualitative visual participatory research methods, 2)
intergenerational research methods, and 3) reproductive epidemiology. These goals will be
accomplished through various coursework, seminars, lab observations, conferences, journal
readings, and tailored mentoring from a committed team of interdisciplinary researchers.
Complemented by support from a dedicated research and training environment at the University
of Pittsburgh School of Public Health and the Department of Psychiatry, this Supplement will
accelerate my trajectory in becoming an independent reproductive health researcher focused on
reducing preeclampsia-associated inequities in Black families.

Public health relevance
Project Narrative This study addresses the knowledge gaps and health inequities concerning preeclampsia among Black women. By utilizing innovative methods such as zine-making and family tree interviews, we will explore Black women's experiences, knowledge, and perspectives regarding preeclampsia. Results are expected to empower Black women to share their stories, contribute to the body of knowledge on preeclampsia, and inform interventions and policies that can improve the health outcomes of Black women and their families.